First in last out: how development informs neurodegeneration

PROJECT SUMMARY
In Alzheimer Disease (AD), magnetic resonance imaging shows early atrophy and loss of functional connectivity
in the medial temporal lobes, which then spreads to the posterior temporal lobe, parietal lobe, and finally the
frontal lobe with relative sparing of the sensorimotor cortex. It is unclear what biological properties drive these
different spatiotemporal patterns. At the other end of the lifespan, over the first few years of life the brain
undergoes rapid cortical expansion and maturation. Whereas primary sensory regions are relatively stable from
birth, there is tremendous cortical expansion in the temporal, parietal, and frontal regions. The networks that are
most plastic mirror those regions most sensitive to AD pathology later in late. Further, adverse developmental
conditions and structural and social determinants of health (SSDOH) such as low birthweight, poverty, and
trauma can negatively impact the development of these networks, and increasing evidence indicates the
repercussions persist throughout the lifespan. This raises the question whether degenerative processes in AD
reflect downstream consequences of adverse developmental trajectories. The most frequent attempt to consider
development and aging together has largely been qualitative in the recognition of the “first in last out” mirroring
between regional changes in the brain. There has been minimal research testing hypotheses linking early
development and degeneration together empirically. We posit two main theories. First, regions with high plasticity
in early life have unique biological properties that inherently make them more susceptible to pathological changes
later in life. Second, the detrimental impact of SSDOH on these regions during development are long-lasting and
will contribute to adverse aging trajectories. Our goal is to determine the degree to which our understanding of
healthy and pathological aging in the brain can be informed by early neurodevelopment. To accomplish this goal,
the project will leverage multiple rich longitudinal datasets with advanced neuroimaging, deep clinical and
cognitive phenotyping, and in-depth genotyping. In Aim1, we will quantify similarities and differences in the
spatiotemporal progression of brain development and degeneration using neuroimaging to empirically test the
spatiotemporal patterns predicted by the “first in last out” hypothesis. In Aim 2, we will determine the impact of
deprivation and genetic risk on functional and structural brain development and degeneration. Finally, in Aim 3,
we will elucidate early-life contributions to accelerated brain aging and susceptibility to degenerative diseases
using genetic risk, neighborhood deprivation, birthweight, and early childhood trauma. Aims 1 and 2 will
harmonize large, extant neuroimaging datasets including birth to three years of age (eLABE, BCP) and aging
and degeneration (ADNI, SORTOUT-AB, HABS-HD) to directly test how normal and abnormal cortical expansion
and brain connectivity development during childhood are reflected in healthy and pathological aging. In Aim 3,
we will leverage lifespan, population level data from the UK Biobank. This proposal brings together a diverse
team with expertise in both brain development, degeneration, and SSDOH.

Public health relevance
PROJECT NARRATIVE In Alzheimer Disease, the progressive spatiotemporal pattern of degeneration follows a characteristic pattern mirroring that of brain development; brain regions developing first are the last to show signs of degeneration. Modifiable early-life developmental conditions and structural and social determinants of health (low birthweight, poverty, and trauma) can negatively impact development of the brain regions which are most plastic during early brain development and are most vulnerable to pathology late in life. This project quantifies the “first in last out” mirroring between regional changes in the brain early in life and in Alzheimer disease by leveraging multiple rich longitudinal datasets with advanced neuroimaging, deep clinical and cognitive phenotyping, and in-depth genotyping.